The Role of Efferocytosis in Inflammatory Arthritis

THE ROLE OF EFFEROCYTOSIS IN INFLAMMATORY ARTHRITIS
Abstract
Rheumatoid arthritis (RA) is a chronic inflammatory disease of the synovial joints which affects 1 in 100 people
globally and millions in the US alone. We noted marked presence of apoptotic cells in the inflamed joints of
arthritic mice. Apoptosis is intricately linked with phagocytosis of apoptotic cells, also known as ‘efferocytosis’.
The current dogma suggests that increased apoptotic cell persistence in tissues inevitably leads to pathology.
However, our data presented in this application suggest that this dogma warrants further testing. First, we show
that systemic injection of apoptotic cells effectively alleviates inflammation in arthritic mice. Further, cell-free
apoptotic cell supernatants or even purified apoptotic cell-released metabolites potently suppress inflammatory
arthritis. Finally, pharmacologic or genetic efferocytosis reduction (not complete ablation) also reduce
inflammation in arthritic mice. Here, we will test the hypothesis that reduced efferocytosis alleviates inflammation
in arthritis through increased release of anti-inflammatory mediators (from uncleared apoptotic cells) and
enhanced corpse processing/degradation (due to reduced corpse load in phagocytes). We will pursue the
following aims: 1. Using mice with pharmacologic or genetic decrease in efferocytosis, we will quantify multiple
disease parameters in arthritis, determine the numbers of apoptotic cells in the inflamed joints, analyze the
phagocyte response, and analyze the metabolomics of reduced cell clearance environments. 2. Generate and
validate a new transgenic mouse model with tissue-specific, inducible reduction of efferocytosis. Our findings
will further our understanding of efferocytosis in homeostasis and inflammation and could open new avenues in
therapeutic designs for the treatment of rheumatoid arthritis.

Public health relevance
THE ROLE OF EFFEROCYTOSIS IN INFLAMMATORY ARTHRITIS Narrative Dying cells can be detected in inflamed joints of human patients and animal models of Rheumatoid arthritis (RA), a chronic inflammatory disease which affects 1 in 100 people globally and millions in the US alone. The current dogma suggests that persistence of dying cells in tissues indicates pathology, as these cells are usually promptly removed by their live neighbors in a process called ‘efferocytosis’. In this application, we present surprising data showing that there are unappreciated benefits of reduced efferocytosis in arthritis and propose to test the dogma and explore the therapeutic potential of this process, which could open new avenues in therapeutic designs for the treatment of rheumatoid arthritis.